Supplement to Society of Behavioral Medicine 2021 Annual Meeting & Scientific Sessions

PROJECT ABSTRACT The Society of Behavioral Medicine (SBM) will hold its 42nd Annual Meeting & Scientific Sessions virtually April 12-16, 2021. This event will feature pre-conference courses on April 12. This supplement application seeks funding in support of pre-conference course fees for up to 200 attendees so that they may be trained in skills necessary to develop behavioral medicine interventions, conduct an optimization trial, adapt interventions for virtual delivery, and write protocols for clinical trials that measure/test social or behavioral outcomes/interventions. SBM is the nation’s leading scientific society dedicated to behavioral medicine, representing approximately 2,400 researchers and clinicians from more than 20 disciplines. SBM’s members include researchers, clinicians, educators, and industry professionals who focus on the development and integration of behavioral, psychosocial, and biomedical theory, knowledge, and interventions relevant to the understanding of health and disease. They work to understand, prevent, and treat chronic diseases such as cardiovascular diseases, respiratory diseases, diabetes, and cancer. They conduct research and translate findings into real-world settings to improve lives while also reducing healthcare costs. SBM’s annual meeting pre-conference courses are a premier forum for disseminating behavioral medicine’s important ideas and breakthroughs. Most of our country's health challenges have behavioral origins. Behavioral medicine and the evidence it generates are more important than ever.

Public health relevance
PROJECT NARRATIVE The Society of Behavioral Medicine (SBM) will hold its 42nd Annual Meeting & Scientific Sessions virtually April 12-16, 2021. The event will feature pre-conference courses that teach attendees the skills necessary to develop behavioral medicine interventions, conduct an optimization trial, adapt interventions for virtual delivery, and write protocols for clinical trials that measure/test social or behavioral outcomes/interventions. SBM’s annual meeting pre-conference courses are a premier forum for disseminating behavioral medicine’s important ideas and breakthroughs, which is of critical importance as most of our country's health challenges have behavioral origins.